Effectiveness Trial of an E-Health Intervention To Support Diabetes Care in Minority Youth

Despite clear evidence of diabetes-related health disparities among African American youth with T1D,
almost no clinical trials have focused on testing behavioral interventions to improve diabetes management for
this population. The lack of research to develop effective interventions to improve health outcomes among
minority youth with T1D is even more concerning in light of the coronavirus 2019 (COVID-19) pandemic. African
American adults and children are likely to be at disproportionate risk to acquire COVID-19 and may be more
likely to suffer from psychosocial and economic burdens of the pandemic. The parent clinical trial upon which
the supplement will build has successfully recruited a large and representative sample of urban, African
American youth with T1D (N=155). The occurrence of the COVID-19 pandemic in the midst of our clinical trial
interjects variance that, if unmeasured, could affect study outcomes in ways that are unknown. Therefore, we
propose to directly measure the effects of three COVID-19 related social/behavioral stressors (psychological
distress, reduced health care utilization and loss of financial resources) on our two primary trial outcomes:
diabetes management and glycemic control. We will obtain data on the impact of the pandemic via three new
data collections obtained for all trial participants over a period of six months. The supplement will also allow us
to evaluate the impact of the novel coronavirus pandemic on the overall health of minority youth with T1D. Our
study is ideally posed to conduct this critical work, which is vital to understanding which social/behavioral factors
associated with the pandemic are affecting health outcomes in this high-risk population. In turn, such data can
inform the development of interventions to mitigate the effects of COVID-19 in the future.

Public health relevance
African American adults and children are likely to be at higher risk to acquire COVID-19 and may be more likely to suffer from psychosocial and economic burdens of the pandemic. The study will measure the effects of three COVID-19 related social/behavioral stressors (psychological distress, reduced health care utilization and loss of financial resources) on diabetes management and glycemic control. Such information could be vital to the development of interventions to mitigate the effects of COVID-19 in the future.